Identification and Characterization of Novel Cis-Regulatory Elements Controlling PTEN Expression

Abstract
It is increasingly appreciated that the non-coding genome can shape gene expression and, consequently,
diseases such as cancer. Beyond a few select examples, however, we know remarkably little about the specific cis-
regulatory mechanisms influencing many key oncogenes and tumor suppressors. While various approaches to
identify candidate cis-regulatory elements (ccREs) on a genome-wide scale have been successful in nominating
large sets putative regulatory regions, many such methods rely on indirect evidence or evidence gleaned outside
of the native context of the cell. Further, pairing the regulatory activity of a given ccRE with its gene partners has
proven difficult. To address this, our groups created the first technologies for functionally defining the regulatory
circuitry of specific genes, CRISPR-Cas9-Based Epigenomic Regulatory Element Screening (CERES). This
platform utilizes nuclease-deactivated (d)Cas9 coupled to epigenomic activator (p300) and repressor (KRAB)
constructs. These constructs are paired with lentiviral short guide RNA (sgRNA) libraries targeting areas of
accessible chromatin surrounding a gene of interest. Thus, we are able to map the effect of both activation and
repression of candidate loci on the expression of a target gene, and thereby define the regulatory elements for
that gene. Powered by this unique in-house technological approach, we are now interested in defining the
endogenous mechanisms controlling expression of important cancer genes.
One of the most frequently altered tumor suppressor genes (TSGs) in human cancers is phosphatase and
tensin homolog (PTEN), which encodes a lipid and protein phosphatase that negatively regulates the PI3K-AKT
pathway, among others. PTEN is mutated or deleted at the genetic level in many tumors. However, a large
fraction of patients exhibit loss of PTEN expression without these associated genetic alterations, suggesting a
potential role for non-coding alterations controlling PTEN expression. Separately, it is also known that
overexpression of PTEN is sufficient to inhibit cancer cell proliferation, drive apoptosis, and stimulate immune
surveillance. Therefore, techniques which target endogenous PTEN for overexpression, for instance through the
manipulation of its cis-acting regulatory elements (cREs), could represent a promising therapeutic strategy.
In this proposal, we will systematically define the key cREs controlling PTEN expression. In so doing, we
will provide a foundation for understanding the role of non-coding mutations as drivers of PTEN loss in human
tumors and germline tumor syndromes. Further, this work will establish a foundation for identifying the
transcription factors and signaling pathways that regulate PTEN expression through these critical cREs, work
which could enable the eventual design of therapeutics that target its genetic regulation.

Public health relevance
Project Narrative: While there is growing evidence that the noncoding genome can modify gene expression, we know remarkably little about the its roles in cancer. In this proposal, we will thoroughly define how the non-coding genome exerts control over an important cancer-related gene, PTEN. We will use this information to both better understand mechanisms of PTEN dysregulation in cancer and establish a foundation for future mechanism-based targeting of PTEN expression as a therapeutic strategy.